Genomic Resource for the Yeast Saccharomyces

PROJECT SUMMARY ? ADMIN CORE The SGD project is managed by an experienced team of scientist that have each been a member of the SGD team for over 10 years. We will utilize management practices to promote an efficient team, allowing enhancement and growth of technology and community engagement while the funding is decreasing. We will maintain the highest quality training for our staff to maintain standards for quality and accessibility. We will provide effective tutorials via text or video for use of SGD and its tools. To provide outreach the students and scientist on the significance and beauty of biology via outstanding short MOOC-like videos and blog posts.

Public health relevance
RELEVANCE TO PUBLIC HEALTH, PROJECT NARRATIVE Saccharomyces cerevisiae is a model for the understanding of chromosome maintenance, the cell cycle and cellular biology. S. cerevisiae can inform genetic medicine via annotation of human disease-related phenotypes and gene function through functional complementation between yeast and human homologs. S. cerevisiae is the most well studied eukaryotic genome and the experimental literature for this yeast contains these results. The SGD provides a comprehensive resource that facilitates experimentation in other systems.